CRISPR and Humanized mice-based Discovery of a Novel Drug target for HCC Therapy

PROJECT SUMMARY
Hepatocellular carcinoma (HCC), the most common type of liver cancer, accounts for over 30,000 deaths each
year in the United States alone. Regrettably, current therapies provide limited clinical benefits in patients with
advanced HCC. Thus, new and more effective therapies for HCC are urgently needed. Most drug target
discoveries and validation approaches employ cell culture-based screening methods or in vivo
immunocompromised or immunodeficient mouse models (e.g., nude mice, NSG mice, etc.). However, multiple
cell culture related artifacts (e.g., 2-D culture, high concentrations of growth factors in media, etc.) and use of
immune-defective mouse models limit the rigorous identification of clinically relevant drug targets and ultimately
negatively impact their translation to clinic. To overcome these limitations and to rigorously identify novel
therapeutic targets in HCC, we combined two state-of-the-art approaches; namely an in vivo epigenome-wide
CRISPR-based functional genomics screening with a humanized mouse model with functional human immune
system. Using these systems, we identified the chromatin modifier NSD3 as a factor that promoted HCC tumor
growth and metastasis in mice with functional human immune system. Mechanistically, NSD3 loss promoted NK
cell-mediated HCC eradication and a highly-selective and efficacious inhibitor of NSD3, BI-9321, blocked HCC
tumor growth in mice with human immune system. Based on these results, we hypothesize that NSD3-mediated
suppression of NK cell-mediated anti-tumor immunity is necessary for the HCC tumor growth and metastasis
and targeting NSD3 represents a novel therapeutic opportunity for treating HCC. The overall objective is to
determine the in vivo role of NSD3 in driving HCC tumor growth and metastasis via suppressing NK cell-mediated
anti-tumor immunity and evaluate in vivo pharmacological targeting of NSD3 for HCC treatment. In Aim 1, we
will first determine the in vivo role of NSD3 in facilitating HCC tumor growth and metastasis. Next, we will
determine the mechanism of suppression of NK mediated anti-tumor immunity by NSD3 and its role in the
regulation of NSD3-mediated HCC tumor growth and metastasis. To answer these questions, we will use a novel
liver fibrosis model that we have developed to study HCC tumor growth and metastasis in conjunction with
immunocompetent humanized mice with transplanted human immune system. Additionally, using organ-specific
and orthotopic spontaneous HCC metastasis models, we will study the role of NSD3 in HCC metastasis. In Aim
2, we will rigorously and comprehensively test the effectiveness of NSD3 inhibitors (BI-9321 and a NSD3-specific
Proteolysis Targeting Chimera (PROTACs)) either alone or with other anti-cancer agents for HCC treatment in
vivo. These studies will utilize established HCC cell lines and HCC patient-derived xenograft (PDXs) and use
humanized mice transplanted with human immune system. Collectively, these studies will determine the role of
NSD3 as a driver of HCC and establish the efficacy of NSD3 inhibitors for treating advanced HCC.

Public health relevance
PUBLIC HEALTH SIGNIFICANCE According to the estimates of the National Cancer Institute over 30,000 Americans will die due to hepatocellular carcinoma (HCC) this year alone; however, regrettably, current therapies provide only limited clinical benefit, and thus, new and more effective therapies are urgently needed for treating HCC effectively. Using an integrative functional genomics approach (humanized NSG mice with human immune system and in vivo CRISPR screening), we have identified NSD3 as a driver and therapeutic target in HCC. The studies proposed in this application will have a significant impact on the biology and therapy of HCC by establishing NSD3 as a driver of HCC and by providing novel drugs for effective treatment of HCC patients.